INFLUENCE OF HELICOBACTER PYLORI AND DUODENAL ULCER ON ENTEROCYTES

To determine acid-base transporters in duodenal enterocytes of healthy human volunteers, to determine if a defect is present in acid-base transport and regulation of phi in duodenal epithelia of patients with duodenal ulcer disease, and to study the effect of eradication of helicobacter pylori on acid-base transport mechanisms in duodenal epithelia of patients with duodenal ulcer disease.